AGING AUDITORY SYSTEM: PRESBYCUSIS AND ITS NEURAL BASES

ABSTRACT/SUMMARY: Administrative CORE This Administrative Core contributes to conducting investigations of the perceptual, neural and molecular bases of presbycusis, (age-related hearing loss ? ARHL). The administrative core provides support to the following aspects of this P01: administration, compliance, organization, budgeting, computing/IT support, coordination of the Program Project External Advisory Group, statistical analyses, across-project publications, human subject recruiting, hearing instrument ordering and fitting and, and annual reporting. This Core will continue to provide excellent support to the other projects and cores, consistent with previous years. Specific activities include: managing human subjects' recruitment program; ordering and fitting hearing aids, facilitating accomplishment of individual Specific Aims and overall program project goals; organizing and conducting biweekly meetings of Project and Core Leaders and Senior Investigators, to assure programmatic and administrative coordination; ensure that Project and Core Leaders meet regularly to act on design and implementation matters; organize overall Program Project meetings every month; exercise prudent management and quality control of components and the project as a whole; monitor processes to fulfill Program's scientific and fiscal goals; carry out institutional policies regarding budget preparation, expenditures, and audits; and coordinate and implement institutional services, Public Health Service (PHS) and USF university policies. Lastly, addition of our new Co-Investigator Biostatistician, and IT/Database expert, elevates the effectiveness and visibility by which we can conduct power analyses, share data, manage and access joint databases, and increase both qualitative and quantitative inter-project communication and peer-reviewed articles over the next 5 years.

Public health relevance
PUBLIC HEALTH RELEVANCE NARRATIVE- Administrative Core Presbycusis, or Age -Related Hearing Loss (ARHL), is the number one communication disorder and number one neurodegenerative condition of our expanding aging population; and comprises one of the top 3 chronic medical conditions, along with arthritis and cardiovascular diseases. The vast majority of people over age 60 are affected by this progressive decline in auditory sensitivity and speech understanding, which are hallmarks of ARHL. Despite this high prevalence of ARHL, there currently are no medical treatments for preventing or reversing permanent hearing loss (ARHL or other types). The thematic focus of this proposal is modulation of presbycusis through biotherapeutics and acoustic treatments. If the experiments proposed here to test hypotheses concerning interventions to modulate the progression of presbycusis are successful, the novel results should lead to clinical trials of the efficacy of these innovative technological, acoustic and drug-related treatments.